In Vivo Modeling of Mitochondrial Complex I Deficiency in Retinal Ganglion Cells

Candidate: The candidate is a MD/PhD-trained clinician-scientist and board-eligible
ophthalmologist currently completing a neuro-ophthalmology fellowship, who will be promoted to Duke
Eye Center faculty in July, 2017. His research interest relates to pathobiology and drug discovery
in mitochondrial optic neuropathies, a class of blinding disease for which effective therapy does
not currently exist.
Career Development Plan: The candidate proposes to create a mouse model of retinal ganglion cell
(RGC)-specific complex I deficiency, predicted to cause particularly rapid and severe RGC
degeneration. The proposed research will allow the candidate to gain experience in animal modeling
of human disease, biochemical and histological assays of mitochondrial dysfunction, and retinal
electrophysiology. Animal models, reagents, and insights developed in this project will serve as
the basis for an R01 proposal to be submitted by the candidate in his final year of K08 support.
Specific didactic courses in neurobiology, drug discovery and translation, toxicology, and
biostatistics, as well as departmental research seminars and advanced training in
responsible conduct of research will be obtained during his K08 tenure, and the candidate
will present his findings regularly at national meetings and submit his work for publication.
Environment: The candidate’s mentoring team consists of accomplished faculty whose wide
range of expertise will be utilized in specific components of the research plan. He will also
benefit from informal mentorship and interactions with world-class clinical and research faculty
in the Duke Eye Center and from immersion in the dynamic intellectual environment and career
development resources available throughout the university. Significant departmental commitment
and deep personal investment by the mentoring team will ensure that the candidate is well
positioned to transition to an independent R01-funded investigator.
Research: Mitochondrial dysfunction frequently results in vision loss from optic neuropathy that
reflects the particular sensitivity of RGCs to impaired aerobic metabolism and increased
oxidative stress. This application’s central hypotheses are that (1) mitochondria-related RGC
degeneration is a cell-autonomous process and (2) RGC metabolism may therefore be manipulated to
make these cells less susceptible to mitochondrial insults. Aim 1 will test the first hypothesis
by creating a mouse with severe deficiency of mitochondrial complex I specifically in RGCs via
conditional knockout of the subunit ndufs4. RGCs in these mice will be assessed for histological,
electrophysiological, and metabolic abnormalities. Aim 2 tests the second hypothesis by
augmenting Hif-1α signaling with complementary genetic and pharmacologic approaches and
assessing whether biasing RGC metabolism toward anaerobic glycolysis makes RGCs resistant
to mitochondrial dysfunction and could represent a viable therapeutic strategy.

Public health relevance
Mitochondrial dysfunction is an important cause of vision loss and is believed to play a mechanistic role in a number of optic neuropathies, most notably in primary mitochondrial optic neuropathies like Leber Hereditary Optic Neuropathy and Dominant Optic Atrophy, but also secondarily in more common diseases like optic neuritis, ischemic optic neuropathy, and toxic optic neuropathies. Currently there are no pharmacotherapies for mitochondrial optic neuropathies that are of more than marginal clinical benefit to affected patients. The studies proposed in this application aim to develop a better molecular understanding of the metabolic perturbations and signaling pathways leading to RGC death in mitochondrial optic neuropathies, as well as potential compensatory mechanisms that may be harnessed for therapeutic intervention in these diseases.